Exploring the role of hypoxia signaling and its inhibition as a therapy for Facioscapulohumeral muscular dystrophy

Abstract
Facioscapulohumeral muscular dystrophy (FSHD) is a neuromuscular disorder for which there is currently no
treatment or cure. Affected individuals have difficulty accomplishing everyday tasks such as lifting one’s arms
above their head, impacting quality of life. Much research has been done trying to elucidate the mechanism of
disease pathology but there has been little congruence apart from apoptosis via DUX4, the toxic protein
associated with FSHD. We took advantage of this phenotype to design a genome-wide complimentary
CRISPR-Cas9 loss of function and activation screens for genetic modifiers of DUX4 toxicity. These screens
identified hypoxia signaling as a novel pathway relating to FSHD pathology with therapeutic potential. Small
molecule inhibitors that target modifiers of this pathway, including the FDA-approved compound everolimus,
reduced DUX4-mediated cell death and FSHD biomarkers, demonstrating the viability of targeting hypoxia
signaling as a potential therapy. In this project we intend to further explore the mechanism of how hypoxia
signaling relates to DUX4-mediated pathology (Specific aims 1). The PI3K/Akt/mTOR signaling axis that
interacts with hypoxia signaling will be modulated through knock-down and/or pharmacological inhibition for
their effect on DUX4-mediated apoptosis. The consequence of autophagy modulation through the mTOR
inhibitor everolimus will be explored. The relationship between DUX4-induced hypoxia and metabolic
dysfunction will be assessed through RNAseq, Seahorse assays of oxygen consumption and extracellular
acidification rates, modulation of oxidative phosphorylation and reactive oxygen species generation. We will
additionally test the therapeutic potential of everolimus in a DUX4-inducible mouse model of FSHD (Specific
aims 2). We will measure effects on muscle function through treadmill endurance, grip strength and ex vivo
contractile force. Using microscopy, we will examine effects on muscle histology and markers of hypoxic
signaling while exploring if this pathology is affected by the metabolic profile of the individual muscles. Lastly,
effect on FSHD biomarkers will be assessed both in the mouse model and validated using patient biopsy
myocytes. If successful, this project will elucidate a new mechanism of FSHD pathology for therapeutic
targeting and identify everolimus as a therapeutically promising compound whose FDA status allows for a
shorter timeframe before patient availability.

Public health relevance
Project Narrative There is currently no treatment or cure for Facioscapulohumeral muscular dystrophy (FSHD), a disorder that affects roughly 1 in 8,000 individuals. We have identified hypoxia signaling as a novel pathway relating to disease pathology which can be targeted upstream through everolimus. This project seeks to elucidate how hypoxia signaling contributes to pathology and the potential of its inhibition through everolimus as a treatment for patients.